The Caregiver-Informed Treatment Engagement (CITE) Program: a Pilot Trial of a Treatment Engagement Intervention for Historically Underserved Youth

Project Summary. Mental illness is common, impairing, and associated with heightened suicide risk among
youth, but access to proper care is sorely limited, particularly for youth of color (YOC). Despite racial inequities
in access to mental health services (MHS) being well known, there has been little meaningful improvement in
MHS access for YOC over time.1 Thus, innovative strategies to improve access to care among historically
underserved populations is imperative and has potential to have a profound public health impact. Given the
challenges YOC face in obtaining adequate MHS, MHS access-promoting interventions designed with
and for families of color in a culturally sensitive manner may be particularly helpful. Brief, accessible,
and culturally sensitive interventions to improve access to and engagement in quality MHS among MHS-
referred youth are understudied in diverse pediatric populations. This proposal seeks to address this critical
gap in knowledge and promote equity in children’s MHS delivery by developing and piloting a virtual group
intervention for caregivers of patients who have been referred to MHS by a pediatric community primary
care center that predominantly serves YOC from low-income backgrounds (the Caregiver-Informed
Treatment Engagement [CITE] Program). For Aim 1, we will form a CITE Steering Committee of
community partners (caregivers and community mental health & primary care providers) to develop
CITE for YOC referred to MHS. The Steering Committee will convene to guide each subsequent stage of
CITE development and piloting. First, the Steering Committee will develop questions to asked in in-depth
interviews (IDIs) of community stakeholders, including caregivers in the local community and community
mental health and primary care providers; IDIs will assess stakeholder views on appropriate foci for a
brief, virtually delivered access-promoting intervention as well as MHS access barriers and facilitators. We
will use these data to inform the targets of the CITE intervention to ensure that CITE appropriately
addresses the needs of the intended audience (YOC from low-income backgrounds). For Aim 2, we will
conduct a pilot RCT of CITE recruiting caregivers of youth referred to MHS by their primary care
provider. Youth will be randomized to CITE or to facilitated MHS referral. We will examine program
feasibility, acceptability, and CITE fidelity. Additionally, youth will be assessed at the start of the study, at
the end of the intervention and at 60- and 90-days post-intervention to examine whether CITE improved
youths’ psychiatric symptoms, caregiver stress, and families’ access to and engagement in MHS. Finally,
for Aim 3, we will examine mechanisms contributing to improved treatment initiation, engagement, and
psychosocial outcomes among CITE participants. Specifically, we will explore whether social
connectedness, MHS related knowledge, CITE acquired cognitive behavioral and parenting -skills, and
parenting stress are associated with CITE engagement and with more favorable mental health outcomes.

Public health relevance
Project Narrative Although race-based inequities in children’s mental health services access have worsened or persisted over time, brief, accessible, and culturally sensitive interventions to improve access to and engagement in quality mental health care among mental health care-referred youth are understudied in diverse pediatric populations. This proposal seeks to address this critical gap in knowledge and promote equity in children’s mental health service delivery by developing and piloting a virtual group intervention for caregivers of youth who have been referred to mental health services by a pediatric community primary care center that predominantly serves youth of color from limited-income backgrounds. The overall goal of this intervention will be to improve proximal (social connectedness, mental health skills, parenting stress) and distal outcomes (treatment initiation, engagement, and psychosocial outcomes) in a diverse pediatric population; innovative strategies to improve access to care among historically underserved populations is imperative and have potential to have a profound public health impact.